Homeostatic regulation of endothelial mechanotransduction

The vascular endothelium's principal responsibility is to support the inflammatory and metabolic
needs of each of the body's organ systems. As such, these cells are highly sensitive to
environmental cues and must be able to respond in a precise manner. The regulation of these
responses likely occurs via numerous competing pathways. Of particular importance are the fluid
shear stress forces imparted by blood flow. The mechanosensitive transcription factors KLF2 and
KLF4 compete with other mechanosensitive transcription factors such as NF-kB and SMAD2/3 to
suppress inflammation and vessel remodeling. Defects in the coupling between these competing
pathways can cause vascular malformations. Klf2/4 are transcriptionally regulated by a MAPK-complex
consisting of the kinases MEKK2/3, MEK5, and ERK5, and the scaffold protein p62. Importantly, the
p62-MAPK-Klf2/4 axis is activated by high shear but suppressed by low shear to permit low
shear-induced inflammation and remodeling. Besides the MAPKs, p62 also interacts with mitochondrial
proteins and polyubiquitinated proteins. As mitochondrial remodeling and proteotoxic stress
responses have been implicated in both shear responses and p62 signaling, this project will explore
the possibility that shear-dependent changes to mitochondrial or ubiquitin homeostasis acts as a
key regulator of p62-MAPK signaling. In aim 1 we will test shear-dependent changes to mitochondrial
function and the role of mitochondria in regulating
p62-MAPK-Klf2/4 signaling. In aim 2 we characterize shear-dependent changes to the ubiquitinome,
determine its role in regulating p62-MAPK-Klf2/4 signaling, and the role of ubiquitin homeostasis
regulating crosstalk between mechanotransduction pathways. The results obtained in this project
will provide insight into the regulation of homeostatic mechanotransduction pathways and may reveal
genetic and environmental drivers of KLF2-4-associated pathologies.

Public health relevance
The vascular endothelium precisely interprets environmental cues and then signals through competing pathways to promote either vessel quiescence or inflammation and remodeling. As such, many vascular diseases result from metabolic disturbances or genetic mutations at key regulatory junctures. This study will identify these decision-makinq elements and test their dvsrequlation in several qenetic backgrounds